Gene Transfer and Somatic Cell Enginerring

ABSTRACT
The mission of the Gene Transfer and Somatic Cell Engineering (GTSC) Core is to develop, validate, and
supply cell-based experimental products for Phase I and II clinical trials so that investigators can evaluate
their safety and potential clinical benefit. The Core supports the implementation of Phase I/II clinical trials
based on cell engineering and adoptive cell therapies. Its major goals are as follows: 1) To develop SOPs
and batch records for cell processing and engineering, vector production; 2) GMP manufacturing: Patient
cell (expansion, purification, transduction, formulation); Vector stocks (plasmid DNA, cell banks); 3)
biosafety/release testing: Patient cells and vector stocks (e.g., phenotype, potency, purity, stability); Gene
transfer/expression; 4) to monitor patients’ samples post-infusion (e.g., FACS, Q-PCR); and 5) to provide
technological and regulatory expertise (GXP, FDA, RAC-NIH).